Reactivity of Manganese and Iron Metalloenzyme Models

Project Summary
Heme proteins participate in many essential biological processes that are important to human health and
disease, and they are targets of both diagnostic and therapeutic treatments. An important subset of these
proteins are enzymes that activate dioxygen (O2) or its reduced analogs (e.g. H2O2). These enzymes utilize the
same iron cofactor to mediate a wide range of reactions, including mono- and dioxygenation of organic
substrates, C-H activation, desaturation, and C-C bond cleavage. How nature tunes the metal center and active
site of these enzymes to mediate such a wide range of functionality is a question of fundamental significance
that continues to motivate significant research. This proposal focuses on the synthesis and reactivity of small-
molecule model complexes of key intermediates, and their related bond-making/bond-breaking events, proposed
in the mechanisms of the thiolate-ligated heme enzymes Cytochrome P450 (CYP), chloroperoxidase (CPO), and
aromatic peroxygenase (APO), and the non-thiolate-ligated heme dioxygenases tryptophan-2,3-dioxygenase
(TDO) and indoleamine-2,3-dioxygenase (IDO). The thiolate-ligated heme enzymes are capable of oxidizing
hydrocarbon C-H bonds, and the proposed mechanism involves H-atom transfer (HAT) (proton-coupled electron-
transfer, PCET) from R-H to an intermediate called Compound-I (Fe=O), followed by hydroxyl transfer
(“rebound”) from protonated Compound-II (Fe-OH) to give the ROH product. However, the rebound step can be
diverted to other pathways, leading to distinctly different reaction outcomes. Many questions remain regarding
the fundamental structural, electronic, thermodynamic and kinetic factors that control both HAT and rebound
steps. In contrast, TDO/IDO are proposed to rely on an Fe(O2) adduct and Compound-II as active oxidants,
although much remains to be learned about this mechanism. Efforts in this proposal will address these questions
through the synthesis and study of biomimetic M=O, M-OH, and M-O2 species that will be prepared with tailored
porphyrinoid ligands designed to stabilize these species and allow for their direct study. These ligands include
ring-contracted corroles (Crl) and corrolazines (Cz), which have a modified porphyrin nucleus which presents a
trianionic (3-) charge to the metal, similar to a thiolate-ligated heme active site. Our previous efforts showed that
the Crl and Cz platforms provide access to novel species not seen with conventional porphyrins, including a
Cpd-I analog with the same spin ground state as found in CYP and CPO, and the first example of a protonated
Cpd-II model. Systematic modifications can be made to these small-molecule models through established
synthetic methodologies, providing atomic-level control over their geometric/electronic structures, and providing
a means to establish structure-function relationships that can be challenging or impossible to obtain when
studying the enzymes alone. The long-term goals of the proposed work are: 1) to address fundamental
questions related to heme enzyme reactivity and mechanism, and 2) to build the knowledge base
regarding synthetic porphyrinoid complexes for applications in small-molecule activation and catalysis.

Public health relevance
Project Narrative The activation of dioxygen by heme enzymes plays a critical role in many fundamental biological processes, including biosynthesis, detoxification, metabolic processes, and energy transfer, all of which directly or indirectly impact human health. This proposal focuses on the synthesis and reactivity of small-molecule analogs of heme enzyme active sites that process and manipulate various forms of oxygen. The proposed efforts will examine bond-making and bond-breaking events at the metal center, providing information for delineating heme enzyme mechanisms, as well as for the design of analogous synthetic catalysts.